Genetic Analysis of Nematode Egg Laying and Co-regulated Behavioral Systems

The long-term objective of this project is to understand how genes specify the functioning of a behavioral
system. The anatomically simple neuromuscular system of the nematode Caenorhabditis elegans consists
of diverse types of neurons and muscles while being sufficiently small and simple to allow a complete
description of its cells, cell lineage, and neural connectivity, facilitating the identification and analysis of
anatomical, developmental, and functional abnormalities caused by mutations. Studies of the C. elegans
egg-laying system and of the neuromuscular systems that control behaviors often coordinately regulated
with egg laying, such as locomotion and feeding, offer opportunities for the analysis of a broad variety of
fundamental biological problems of relevance to many human disorders. The major issue that this project
will address is the mechanisms used by animals to respond to environmental cues and stresses. More
specifically, this project will determine how low oxygen levels and multichromatic light (color) affect C.
elegans egg-laying behavior and locomotion, respectively, and will use these C. elegans behaviors as
readouts to analyze important evolutionarily conserved pathways that respond to such cues and stresses.
The genetic, molecular, cellular, and neural-circuit bases of these responses will be defined. The major
focus will be on mechanisms that mediate behavioral responses to oxygen deprivation, which profoundly
affects cellular and organismic physiology in humans and is responsible for the cardiac damage in heart
attacks as well as for ischemic damage to the kidneys, nervous system and other organs. The evolutionarily
conserved EGLN/HIF pathway mediates responses to oxygen deprivation, has been implicated in many
human disorders, and has defined major therapeutic targets for cancer. This aim will identify new
components of this important pathway and reveal how this pathway acts both broadly and with cell-type
specificity to control animal physiology and behavior. The second and more exploratory aim will determine
how, despite lacking eyes and opsins (the class of photoreceptor proteins thought to be essential for color
discrimination), C. elegans can distinguish different colors. Color detection is used by animals of diverse
phyla to sense and respond to colorful natural environments. The proposed studies of the responses of C.
elegans to multichromatic light will address a fundamental and intriguing biological question: what
mechanisms allow cells that lack opsins to respond to multichromatic light? More specifically, this aim will
determine how the evolutionarily conserved Epithelial Sodium Channel (ENaC), which in mammals is crucial
for fluid and ion homeostasis, functions in C. elegans to mediate responses to colored light. These studies
should both reveal novel aspects of ENaC channel regulation and function and provide novel insights into
opsin-independent photobiological responses, which are displayed by a variety of light-sensitive non-visual
human cells, including the retinal pigment epithelial (RPE) cells of the mammalian eye.

Public health relevance
PROJECT NARRATIVE An understanding of the fundamental mechanisms that control animal development and behavior is key to an understanding of many aspects of human health and disease. This project aims to reveal molecular mechanisms that mediate behavioral responses by the experimentally tractable roundworm Caenorhabditis elegans to the environmental stress of oxygen deprivation (hypoxia) and the environmental cue of multichromatic light (color). C. elegans shares many genetic, molecular and cellular features with more complicated animals, including humans, and these studies should provide insights concerning both fundamental aspects of human biology and disease processes as diverse as blindness, heart disease and cancer.